Core A: Administrative Core

PROJECT SUMMARY/ABSTRACT – ADMINISTRATIVE CORE
N-nitrosamines are a family of chemicals that include some of the most potent mutagens known. N-nitrosamines
are a major concern for people who live near the Olin Chemical Superfund Site, which is contaminated with
millions of gallons of waste containing high levels of N-nitrosodimethylamine (NDMA), a probable human
carcinogen. NDMA is also a concern of the Passamaquoddy Tribe, because the water treatment methods used
for their drinking water are known to lead to formation of NDMA. The mission of the Administrative Core is to
enable a Systems Approach wherein impact on public health is made possible via a network of interactions and
interdependencies among Projects, Cores, and stakeholders. The resulting ‘MIT SRP Interactome’ results from
research meetings, enrichment activities, workshops, retreats, poster sessions, trainee collaboration meetings,
and meetings with stakeholders. Team building will be further strengthened via adoption and enhancement of
team science values. Translation will be fostered via support of Project and Core leaders in developing and
executing their Investigator Initiated Research Translation plans and by continual input and suggestions from
the Administrative Core leadership, and in particular the Research Translation Coordinator. In addition to its
Systems Approach, other innovative goals include facilitation of bidirectional communication with the National
Toxicology Program to enable the MIT team to cater technologies to meet the needs for high-throughput screens
for chemical safety and working with the Community Engagement Core (CEC) to deploy N-nitrosamine sensors
and remediation devices that destroy N-nitrosamines. Specific Aim 1 is to lead and coordinate in order to
achieve a robust programmatic ‘MIT SRP Interactome’ that will give rise to results and deliverables that
contribute to the protection of human health from hazardous substances. Specific Aim 2 is to partner
and promote by translating knowledge and technologies to local, state, national, and tribal
organizations. Specific Aim 3 is to achieve a broader impact via dissemination of knowledge and by
building a better future for the next generation of leaders in environmental health sciences.
Communication and data sharing will be further strengthened by the Data Management and Analysis Core
(DMAC), which will deliver computational methods for integrating data streams from across disciplines in order
to contribute to a better understanding of risk, improved ability to predict disease, and new opportunities for
interventions. The Administrative Core will also work closely with the Research Experience and Training
Coordination Core (RETCC) to coordinate training and support for trainees. Taken together, the Administrative
Core is the cog that drives the program forward by creating tight collaborations and interdependencies within the
MIT SRP and with its local, state and national stakeholders, that together enable MIT SRP solutions that give
rise to improved public health.

Public health relevance
PROJECT NARRATIVE – ADMINISTRATIVE CORE The Administrative Core plays a central role in orchestrating the MIT Superfund Research Program (SRP) so that many types of data can be combined to gain knowledge that will guide decisions on safety and cleanup, and so that work can be done hand-in-hand with community members to detect and destroy hazardous chemicals using novel filtration devices (to be created by MIT SRP engineers). The Administrative Core creates and strengthens connections among members of the MIT SRP, and between the MIT SRP and other stakeholders at local, state, national, tribal and global levels. By ensuring effective teamwork within the MIT SRP and between the MIT SRP and its stakeholders, MIT research, teaching, training, and community engagement will be optimized for their greatest impact.